Polygenic Prediction of Suicide: Clinical, Ethical and Psychosocial Impact

Suicide is a leading cause of death in the U.S. and a major public health problem, with hundreds of thousands
of suicide attempts and tens of thousands of deaths annually. Unlike several other leading causes of death,
progress in reducing suicide rates has been limited, in part because of an extremely limited ability to predict
which individuals will attempt or die by suicide. Indeed, a recent meta-analysis of studies that attempted to
predict suicidality based on putative risk factors found that predictive accuracy was barely better than chance
and had shown no significant improvement over five decades. In this context, recent years have seen
increasing enthusiasm regarding the prospect of using genetic information to predict suicide risk. In particular,
researchers have recently developed polygenic risk scores (PRS), which use data from genome-wide
association studies (GWAS) to estimate a person's relative genetic susceptibility to a particular health outcome
(in this case, suicide) by aggregating all risk variants present in the person's genome, weighted by the strength
of each variant's association with the outcome in question. Early research suggests that PRS for suicide have
significant predictive power, and the prospect of using PRS to predict individuals' risk of suicide has generated
significant excitement as a possible precision medicine tool for identifying people in need of intervention and
ultimately preventing suicide deaths. However, there are also significant reasons for concern. For instance, if
high PRS for suicide are misinterpreted in a fatalistic manner, this could lead to hopelessness among patients
or premature reliance on intrusive or coercive approaches to risk-reduction among family members and
clinicians. Low PRS could potentially lead to false reassurance. PRS could also affect treatment-related
beliefs, patient-provider relationships, and stigmatization of at-risk individuals. The proposed research will
investigate attitudes and beliefs about the prospect and implications of using PRS to predict suicide risk in
clinical care, using surveys and qualitative interviews of primary care patients with symptoms of depression
(Aim 1) and of primary care physicians and psychiatrists (Aim 2). Among the parameters examined for patients
will be willingness to receive genetic predictions of suicide risk and emotional reactions to the receipt of such
predictions; anticipated impact of suicide PRS on self-perceptions, reproductive decision-making, life planning,
familial and interpersonal relationships, treatment-seeking, patient-provider relationships, and actual suicide
risk; and other perceived risks and benefits. Physicians will be asked about perceived clinical utility and likely
impact on clinical decisions, along with other perceived benefits and risks. We will also conduct an
experimental study of physicians, examining the effects of PRS-based suicide risk information (i.e., mock
electronic health record summaries) on putative decisions about clinical care (Aim 3). By investigating how the
prospect of PRS-based suicide prediction is received by patients and physicians, the proposed research will
help to anticipate the ethical, clinical, and societal implications of polygenic prediction of suicide.

Public health relevance
Project Narrative. The proposed research will examine reactions to the prospect of using patients’ genetic information to predict suicidal behavior—an approach that has generated enthusiasm as a potential precision-medicine tool to reduce the public health impact of suicide, considering the difficulty of predicting suicide risk using currently available methods. The research will use surveys, interviews, and experimental methods to understand attitudes and beliefs among primary care patients in the United States with symptoms of depression, as well as primary care physicians and psychiatrists, about the prospect of using polygenic risk scores (PRS) for this purpose. It will generate data that will be valuable in helping to anticipate the ethical, clinical, and societal implications of genetic prediction of suicide.